Chemical Countermeasures Collaboration - Chemicals Affecting the Nervous System

The primary objective of this IAA is to support the research and early development of medical countermeasures (MCMs) against chemical threats that target the nervous system. Projects supported under this IAA were developed jointly between the NIH/NIAID/CCRP and the DoD/USAMRICD. Chemical threats to the nervous system include chemical warfare nerve agents, pesticides, and various toxic industrial chemicals/materials. As such, the research purpose of this IAA is to develop in vitro, in vivo, and/or ex vivo models of the acute and/or chronic long-term toxic effect of exposure to the chemical threats for the purpose of medical countermeasure development.